Control of primordial germ cell quiescence by niche basement membrane and Notch signaling

SUMMARY
A detailed knowledge of each step of germ cell development is critical for understanding the developmental
basis of human infertility and for reaching the goal of differentiating gametes in vitro. Primordial germ cells
(PGCs) are the embryonic precursor cells that give rise to sperm and eggs, and are therefore essential for
fertility. During early embryogenesis, PGCs enter a temporary period of cell cycle and transcriptional
quiescence that is important for preserving their developmental potential. Subsequently, PGCs proliferate then
differentiate into germline stem cells in order to produce gametes. These regulatory events are guided by
poorly understood signals arising from somatic niches. For example, mammalian PGCs receive critical but
unidentified differentiation signals from the genital ridge. Our poor understanding of how niche signaling
regulates PGCs is due in part to the paucity of model systems in which niche-PGC interactions can been
investigated in molecular detail.
Our long-term goal is to use the experimental strengths of C. elegans to determine how somatic niche
cells in the embryo regulate PGC quiescence. Many fundamental and deeply conserved insights into germ cell
biology have come from studies in invertebrate models, including C. elegans. Embryos contain two PGCs,
which are enwrapped by two somatic gonad cells (SGPs) to form the primordial gonad. SGPs act as a niche to
ensure that PGCs remain quiescent until the embryo hatches. We have found that SGPs accomplish this in
two ways. First, they are required to template a basement membrane (BM) that surrounds the primordial
gonad. Second, they are needed to relay a signal originating from the gonadal BM that prevents embryonic
PGCs from exiting quiescence. While the identity of the signal is unknown, the loss of PGC quiescence that
occurs when BM is depleted is accompanied by activation of the Notch signaling pathway and is suppressed
by mutations in the GLP-1 Notch receptor. Our central hypothesis is that BM maintains PGC quiescence by
inhibiting a Notch ligand in SGPs, preventing it from activating the GLP-1 receptor in PGCs. The specific
objectives of this proposal are to identify the SGP Notch ligand and the BM proteins and receptors that
regulate PGC quiescence, and to determine how BM and Notch signaling components interface. These
foundational studies will enable us to develop the C. elegans gonad primordium into a powerful new model
system to investigate the molecular basis of niche signaling to PGCs. Our findings will reveal specific new
insights into how niche BM controls Notch signaling to preserve PGC quiescence, informing studies of
mammalian PGC regulation. They will also more broadly illuminate how niche BM can control Notch signaling -
a critical regulator of many stem cell systems.

Public health relevance
PROJECT NARRATIVE Primordial germ cells are the cells in the embryo that will develop into gametes (sperm and egg), and are therefore essential for human fertility. The goal of this proposal is to learn how the local cellular environment surrounding primordial germ cells ensures that they develop properly and are capable of producing gametes. Our findings will provide basic insights into primordial germ cell development, which is an important step in understanding and preventing human infertility.